Translational Research in Biomaterials

ABSTRACT
This application is for an administrative supplement for one additional slot for the parent award NIH T32
parent award T32EB006359, Boston University's NIH training program, Translational Research in Bio-
materials (TRB). The TRB mission is to train PhD students as interdisciplinary and translational research
scientists and engineers. The TRB trainees acquire a fundamental and quantitative understanding of mate-
rials, biomaterial-tissue responses, and molecular and cell biology, as well as interdisciplinary training expe-
riences and education that promote discussion and scientific inquiry in areas outside students’ “comfort
zones,” such as in business and clinical trials. New for this renewal are the following: a junior faculty men-
toring plan, integrated student governance, better data collection, new courses, professional development
workshops, student founded and led translational MInT program, Fireside chats with key opinion-leaders,
peer mentoring program pairing first year trainees with senior trainees, and more targeted efforts for un-
derrepresented minority recruitment.
The cornerstones of the TRB program are the curriculum and the program elements that combine interdis-
ciplinary research, quantitative science, engineering, and translational-based courses in clinical trials and
business, with student-organized seminar club, dinners with clinicians, training in professional ethics, indi-
vidual development plans, and professional workshops/ career panels. Our aim is to teach the unique skills
and competencies that are essential to thrive in a multidisciplinary collaborative team striving to meet com-
mon goals in research, development, translation, and, ultimately, commercialization. Since our initial funding
in 2009, 55 students have participated in the TRB training program: 33 were supported with NIH funds and
11 were co-funded by the BU Departments of Biomedical Engineering and Chemistry. We have accom-
plished our demographic and training mission: 32 women (54%), 27 men (46%), 31% minority, 93% reten-
tion; 100% employment; 23 current students. The TRB trainees have excelled on multiple fronts, including
157 published papers, 24 patent applications over 230 oral and poster conference presentations, 16 com-
petitive individual NSF or NIH fellowships. TRB alumni hold positions ranging from Assistant Professor at
Rice University, to a postdoctoral fellowship at Harvard, to co-founding biomedical start-ups (e.g., Phar-
machk).

Public health relevance
NARRATIVE Training young scientists and engineers in translational research in biomaterials facilitates the translation of biomaterials-based technologies to the clinic. Specifically, the Translational Research in Biomaterials (TRB) curriculum enables students to develop the creative, analytical, quantitative, and professional skills they need to make new discoveries that will revolutionize fields ranging from diagnostics and drug delivery to tissue engineering. These advances will improve patient care in multiple areas of medicine and ensure an academic and industrial workforce to meet the challenges of the 21st century.